South Texas Alzheimer's Disease Center Imaging Core

The Imaging Core (IC) highlights the strengths of the South Texas Alzheimer Center (STAC), which
has a critical mass of infrastructure, imaging expertise, and training programs. It is comprised of the Research
Imaging Institute (RII), the Department of Radiology and the Radiological Sciences Graduate Program
(RSGP). The RII is a research unit that has supported biomedical research in South Texas for 30 years,
including numerous international collaborations. PI Fox has >100 publications/ multiple grants with Genetics
and Multiomics core PI, Blangero at UTRGV. The RII is housed in the same building as the Clinical Core
(CC) and Population Neuroscience Core at UTHSA and includes: magnetic resonance imaging and
spectroscopy (MR/MRSI) for humans (3-T) and animals (7-T, 12-T); positron-emission tomography (PET) for
humans and animals; two medical cyclotrons for PET-isotope production; and, radio-pharmaceutical production
facilities, including an FDA-approved (ANDA & IND) cGMP commercial-production facility. Ancillary capabilities
include in-scanner performance-control systems (stimulus delivery and response recording); image-guided,
robotic transcranial magnetic stimulation (irTMS). RII faculty provide expertise in image acquisition (including
radiochemistry and pulse-sequence editing), image preprocessing, and sophisticated analysis, including
machine learning, AI. Image archiving, analysis and sharing (XNAT) capabilities are provided by virtual
computers, a new on-site high-performance compute cluster (GENIE) and ready access to the Texas
Advanced Computing Center. The Department of Radiology provides neuroradiologic expertise (including a
fluoroscopic suite dedicated to research LP) and 2 additional 3T MRI and a PET/CT scanner, also in the same
building as the CC. The STAC is a site for several clinical trials (AHEAD 3-45, markVCID, GOBS, TARCC)
demonstrating ability to acquire high quality MRI (with DTI, CVR, fcMRI), amyloid, tau and FDG PET. We
routinely obtain ADNI-3 protocol MRI as part of clinical care and have implemented the protocol across 5 MRI
scanners (3 at UTHSA and 1 each at Laredo and Harlingen CC sites). We will obtain these MRI scans on all
CC enrollees, annually, and will also obtain amyloid (PIB) and tau (T807, flutaucipir) PET to categorize
enrollees using A/T/N criteria. We have recruited a neuroradiologist, radiochemist and computational analyst in
the past year. We have implemented a post-mortem whole brain MRI protocol (with Neuropathology core). IC
faculty are leaders in multimodal MRI, functional MR and in applying and developing novel image analysis
methods to answer questions relevant to ADRD; they are leading MRI harmonization/analyses within
CHARGE, iSHARE consortia and in SPRINT-MIND. The RSGP supports the STAC REC by overseeing 3
doctoral degree programs directed by IC core leaders: Neuroscience Imaging (P. Fox), Human Imaging (G.
Clarke), and, Diagnostic Radiology (M. Habes) and partners with an R25 Medical Scientist Training Program
(MSTP, PI Cavazos who also leads the STAC REC) to train MD/PhD scientists.